SUPPORT SERVICES FOR RADIATION AND RELATED STUDIES

The purpose of this contract is to provide support services for the conduct and management of epidemiologic investigations of cancer directed by the Radiation Epidemiology Branch (REB), Epiemiology and Biostatistics Program (EBP), Division of Cancer Etiology (DCE), National Cancer Institute (NCI), National Institute of Health (NIH).